Cortical Networks Encoding Higher-Order Memories that Elicit Fear

Project Summary
Exposure to traumatic events can result in intrusive fear memories that can be evoked not only by stimuli that
were present during the event, but also by stimuli that have gained the ability to activate fear through higher-
order process despite never being directly paired with trauma. Such fear memories are adaptive but can also
contribute to the development of post-traumatic stress disorder (PTSD), with patients often experiencing
flashbacks and/or reoccurring memories related to the traumatic event. While a large body of research has
focused on identifying the neural substrates responsible for fear memories retrieved by stimuli that were present
and directly associated with trauma, much less is known about encoding and retrieval of higher-order
conditioning, which allows stimuli not present at the time of trauma to evoke fear responses. It is therefore
important to understand the neural substrates that support the encoding and retrieval of higher-order fear
memories. Without this knowledge, determining the precise relationship between intrusive memories and PTSD
is unlikely. To address this, the proposed research will use chemogenetic and in vivo electrophysiological
recording methods in freely moving rats to investigate the necessity of network signal properties underlying the
encoding and retrieval of higher-order conditioning, and their coordination across cortical regions. This
contribution is expected to be significant because it will yield a detailed understanding of the neural
substrates of adaptive higher-order fear memories, which may inform the link between intrusive
maladaptive memories and PTSD. Such findings also have the potential to inform treatments for PTSD,
especially trauma-focused therapies, in which patients specifically focus on the memory of the trauma or
other trauma reminders.

Public health relevance
Project Narrative The proposed research is relevant to public health because it is focused on the neural mechanisms of intrusive traumatic memories, a hallmark symptom of post-traumatic stress disorder (PTSD). The proposed research will examine the functional contribution of cortical regions to complex behavior across multiple levels of analysis (cell, physiology, behavior). The project is relevant to NIMH’s mission because it will provide new knowledge about the neural bases of learning, memory, and emotion, which may relate to clinical symptoms when dysfunctional.